Circuits for deviance detection in V1

PROJECT SUMMARY
Brain responses to stimuli are not static over time but are dynamically modulated by the context of concurrent
and preceding stimuli. This supports the rapid detection of behaviorally relevant information which may be key
for survival in complex environments. In the visual system, neural activity as early as primary visual cortex (V1)
is increased to stimuli that deviate from contextual patterns, a phenomenon termed “deviance detection.” In
human EEG recordings, this deviance detection is reflected in the “mismatch negativity”, an early scalp potential
elicited by rare stimuli in, for example, an “oddball” sequence. Visual mismatch negativity, and likely deviance
detection, is altered in many neurological and psychiatric disorders, indexing fundamental visual processing
deficits that may undermine how affected individuals relate to their world.
Despite this basic and clinical significance, the neural circuitry for generating deviance detection is unknown.
Our past work has utilized mice to address this question at a basic level, given the powerful set of genetic and
optical tools available in this animal. We identified robust deviance detection in mouse V1, particularly in
pyramidal neurons (PYRs) in superficial cortical layers (layer 2/3). We then showed that V1 deviance detection
is dependent on i) local GABAergic interneurons and ii) top-down inputs from higher cortical areas (anterior
cingulate; ACa). Exactly how these circuit elements interact to modulate V1 activity in context, producing
deviance detection to novel stimuli, is unclear.
The current project will build these preliminary insights to test a detailed circuit hypothesis of how deviance
detection responses emerge in V1 in layer 2/3. Specifically, we propose that top-down input to V1 (from ACa)
engages a mutually inhibitory interneuron circuit, involving namely vasoactive intestinal peptide- (VIP) and
somatostatin- (SST) neurons. This serves to transiently modulate the excitability of subsets of PYRs dependent
on their feature selectivity, attenuating responses to redundant stimuli and augmenting responses to deviant
stimuli. To test this hypothesis, we will present visual “oddball” and control sequences to awake mice (which
allows us to parse true deviance detection from the absence of simple neural adaption). We will employ two-
photon calcium imaging and spatiotemporally precise optogenetic interventions (one and two-photon) to record
and manipulate cell-type specific activity dynamics in V1. In aim 1, we will optically probe PYR excitability with
single cell resolution during specific phases of the oddball paradigm, assessing PYR responses relative to their
feature selectivity. Next, we will optically suppress SST and VIPs in V1 (aim 2) and then top-down ACa inputs to
V1 (aim 3) at specific phases of the oddball paradigm while recording PYRs, SSTs, and VIPs to precisely test
predictions of our circuit hypothesis. This focused, technologically advanced approach, applied during a passive
and highly translatable sensory stimulation paradigm, will provide fundamental insights which could transform
how basic visual processing and central visual circuitry is studied and understood in health and disease.

Public health relevance
Narrative The ability to process sensory stimuli in the context of previous stimuli is a fundamental function in mammalian brains. Context processing is altered in the visual system in a number of diseases, including autism spectrum disorders and schizophrenia, undermining how affected individuals perceive and relate to a changing environment. In order to understand the biological mechanisms of basic contextual modulation in primary visual cortex, this project applies a suite of cutting-edge optical tools to study neural circuits in mice, providing potentially new insights into understanding and treating visual processing pathology.